Cellular reprogramming to promote longevity, resilience, and repair in motor unit degeneration

PROJECT SUMMARY/ABSTRACT
The global population is aging rapidly – the number of adults over 65 is expected to double by 2050.
Chronological aging is an established risk factor for neurodegeneration and leads to dysfunction and loss of the
motor unit (MU; a motor neuron and all the myofibers it innervates). Further, genetic variants may accelerate
biological aging and acquired cellular damage in the nervous system. However, aged mammalian tissues retain
an epigenetic signature, and recent publications highlight strategies such as cellular reprogramming to restore
youthful tissue resilience. My long-term career goal is to obtain a tenure-track clinician-scientist position at an
academic institution and establish a translational research program. Such a position will allow me to achieve my
long-term scientific goal to investigate cellular aging of the nervous system in the setting of genetic predisposition.
My short-term scientific goal and the foundation of this proposal is to test the hypothesis that targeting biological
aging pathways independently and in conjunction with disease-specific gene therapies may provide a promising
avenue to develop new therapeutic strategies targeting neurodegeneration. My doctoral project investigates
Kinesin-1 Family Member 5A (KIF5A), a known susceptibility gene for the neurodegenerative disease
amyotrophic lateral sclerosis (ALS). Mutant Kif5a mice demonstrate loss of functional MUs in the context of injury
and aging, with observable pathological correlates. These data support a prominent role of KIF5A in MU
maintenance, suggesting mutant KIF5A is unable to combat biological challenges such as injury or age. The F99
phase of this award will test the hypothesis that ALS-associated Kif5a mutations lead to haploinsufficiency and
use viral vectors to manipulate Kif5a expression. The K00 phase will build upon my experience with MU
physiology, pathology and viral vectors to study aging and neurodegeneration more broadly. As a postdoc, I will
study the interdependence between physiological triggers of disease (genome and exposome), biological aging,
and phenotype. Specifically, the proposed work will investigate AAV-mediated cellular reprogramming of
transcription factors Oct4, Sox2, and Klf4 to improve MU longevity, resilience and repair, and then apply this
approach to genetic MU disease. Aim 2A will test the effect of induced, transient reprogramming of individual
MU cell types on functional, epigenetic, transcriptomic, and histopathological outcomes. Aim 2B will investigate
the value of cellular reprogramming in enhancing aged MU repair and resilience when faced with MU insults.
Aim 2C will test the utility of multi-transgene delivery of longevity-promoting cellular reprogramming
independently and in conjunction with existing gene therapies to have a synergistic effect on disease phenotype.
These studies will provide critical information about mechanisms of MU longevity, resilience and repair and will
test a therapeutic approach that has implications for all age-related neurodegenerative diseases. In addition, the
proposed career development plan was thoughtfully designed to develop the technical expertise, science
communication skills, and mentorship experience essential to becoming an independent investigator.

Public health relevance
PROJECT NARRATIVE Individuals with age-related neurodegenerative disorders often experience declining neuromuscular function that may be linked to accelerated biological aging, but clearer knowledge of these degenerative processes is needed to guide the development of new, effective therapies. The predoctoral (F99) phase of this award will use robust mouse models to thoroughly investigate neuromuscular dysfunction when faced with genetic disease, aging, and injury, as well as use of gene therapy as a treatment strategy. The K00 portion of this award will investigate cellular reprogramming of the motor unit as a way to improve longevity and resilience when faced with genetic disease, aging, and injury.